Leveraging innovative technologies in basic and clinical cancer research

This application requests funds to continue the highly successful Cancer Biology T32 training program at the Stanford University School of Medicine. The current application will present a new vision for this training program, in which the innovative technologies developed and used at Stanford will become a cornerstone of the cancer research program, in a proposal entitled “Leveraging innovative technologies in basic and clinical cancer research”. The goal of this training program is to provide the very best training for its predoctoral trainees so that they become successful and independent leaders in the field of cancer research. The program accomplishes this goal by providing each trainee with a broad and comprehensive curriculum, a vast array of educational resources such as seminars, lectures, conferences and workshops specifically geared toward the biology of cancer, a faculty comprising 49 exceptional preceptors with extensive experience in cancer research mentoring, and an unparalleled research environment. The success of the training program is demonstrated by its track record of attracting outstanding and talented predoctoral candidates to Stanford University and placing graduates of the program in high-profile competitive cancer research positions in academia, industry, and medicine. During the next 5-year period, there will be a number of new initiatives. The program will focus on leveraging a variety of cutting-edge technologies pioneered by T32 faculty at Stanford to better understand cancer development and to help develop improved cancer diagnostics and therapeutics. The strong technology emphasis of the program is a key strength that will promote a truly multidisciplinary approach to cancer research, enabling collaborations between individuals in varied fields such as systems biology, functional genomics, epigenetics, immuno-oncology, and cancer stem cell biology. In addition, the research conducted by T32 preceptors has a significant clinical focus, with the goal of ultimately improving cancer care. Our curriculum, which we have designed to provide trainees with a solid core of cancer biology coursework while allowing flexibility in electives to match individual needs in areas of specialization (e.g., computational biology), will now also include technology-oriented coursework. We have also introduced a clinical course to expose students to the translational side of cancer biology as well as “T32 chats” to teach students about translational cancer biology and pitfalls associated with various technologies. We are promoting career development by providing leadership opportunities for students, access to teaching opportunities, and career workshops with alumni to give exposure to different potential career options. To ensure optimal mentors, we will also have a new rigorous selection process for T32 preceptors. To ensure the most robust training program possible, we consult with internal and external advisory committees comprising highly accomplished scientists at Stanford and peer institutions. These collective experiences will provide T32 trainees with a strong foundation in cancer biology to prepare them for independent careers and for becoming the next generation of leaders in this field.

Public health relevance
PROJECT NARRATIVE This is the renewal application for the T32 training grant originally known as “Cancer Etiology, Prevention, Detection and Diagnosis,” which is in its 44th year, and which is entitled in the current application “Leveraging innovative technologies in basic and clinical cancer research”. The program has developed a thriving and robust training environment as well as an effective administrative infrastructure that has been very successful in attracting highly qualified trainees to Stanford University to be educated in cancer biology. During the next funding period, we propose to implement a new vision in which we incorporate innovative technologies into cancer research to enhance both the training and the research projects of our predoctoral trainees, helping them to become independent scientists that take research or clinical positions in academia, biotechnology industries, government laboratories, and the clinic, and to ultimately become leaders in the field of cancer biology.